CELLULAR POLYPEPTIDES ASSOCIATED WITH METASTASIS OF RAT MAMMARY TUMOR CELLS

This project was initiated to identify those polypeptides that specifically relate to the metastatic process as the first step toward their purification and identification. Utilization of metastasizing and non-metastasizing cells derived from the same parent population of tumor cells is fundamental to this project. We have confirmed that the TMT-081-MS cells do metastasize in syngeneic rats and that the TMT-081-NM cells do not metastasize in syngeneic rats. Radiolabelling of these cells with 14-C amino acids has revealed several qualitative and quantitative differences in their polypeptide patterns. The most intensely labelled spots that occurred in the TMT-081-MS cells were (MW/pI) 67/5.5 and 50/4.5 and the most intense spots that occurred only in the TMT- 081-NM cells were 46/6.7 and 38/6.1. When a 32-P-radiolabel was used with these cells, a number of polypeptides could be observed that were not located from the 14-C labelling. The most intensely 32-P labelled spots occurring only in the metastatic cells were 98/4.7 and 24/4.5. Those polypeptides that were approximately threefold greater in intensity in the metastatic cells compared to the non-metastatic cell: were 14/5.2, 15/5.4 and 12/6.3. The polypeptides of 40/5.9 and 40/5.8 were at least threefold greater in the intensity of 32-P label compared to the corresponding polypeptides in the metastatic cells. A number of subclones of the metastasizing TMT-081-MS cells have been derived from metastasis in Wistar/Furth rats. These subclones possess metastatic capacity and will be used in further experiments.